Isolating causal roles of norepinephrine neuromodulation in mediating distinct components of attention control

PROJECT SUMMARY/ABSTRACT
When faced with environmental uncertainty, optimum top-down control facilitates attention shifts and improves
performance. Several functionally distinct stages of attention are well stablished in psychology. Recent studies
have associated some of these cognitive constructs with specific brain structures. However, less is known about
the neurobiological mechanisms that transform contextual information into distinct components of attention
control such as selection of relevant sensory inputs, perceptual decision and motor action responsible for
adaptive behaviors in humans. Lack of appropriate attention control leads to various attention disorders such as
attention-deficit/hyperactivity disorder (ADHD). Our long-term goal is to dissociate distinct neuronal processes
underlying adaptive behavior, particularly neuromodulatory contributions to cognitive control within interacting
brain structures. Neuronal activity in the anterior cingulate cortex (ACC) and dorso-lateral prefrontal cortex
(dLPFC), two crucial brain areas involved in cognitive control are strongly regulated by norepinephrine (NE)
neuromodulation from the locus coeruleus (LC) in the brainstem. The LC-NE neuromodulatory system projects
throughout the cerebral cortex, and has been linked to sensory processing regulation, arousal and attention. Our
preliminary data in monkeys show that spatially selective attention strongly modulates spiking dynamics of NE
neurons in the LC including an increased spiking to attended visual stimuli. Moreover, optogenetic activation of
these LC-NE neurons enhanced attentional performance. Our central hypothesis is that: 1) the LC receives
contextual information about behavioral performance from the ACC, and is activated with increased performance
errors; 2) LC-NE neuromodulation differentially regulates neuronal activity in the ACC and dLPFC respectively
to mediate motor selection, and sensory and perceptual decision selections of attention control. To test these
hypotheses, we will isolate neurophysiological correlates of performance errors, and attentional shifts in sensory
relevance, perceptual decision criterion and motor criterion within the LC, ACC and dLPFC in monkeys. We will
optogenetically activate LC-NE neurons while simultaneously record from the ACC and dLPFC to test which
aspects of LC-NE activity dynamics (tonic and stimulus-locked phasic burst spiking) causally regulate ACC and
dLPFC to mediate distinct components of attention control. The results from this proposed study will provide a
direct, detailed neurobiological understanding of specialized neuromodulatory contributions that transform
contextual information into different stages of attention control in improving adaptive behavioral performance in
humans. This will further expedite progress in better classification and identifying potential therapeutic targets
for various attention disorders associated with functionally specific deficits.

Public health relevance
Project Narrative The limited success of clinical interventions in attention- deficit/hyperactivity disorder (ADHD) can be attributed to poor understanding of the neurobiological mechanisms that contribute to the heterogeneous set of behavioral dysfunctions associated with attention control. The proposed research will investigate how different stages of attention control– selection of sensory input, decision and motor responses are generated in the nervous system. These findings will advance basic understanding of specialized circuit elements of distinct components of top- down attention control leading to better defined diagnosis and more tailored therapeutic interventions of attention disorders.